Engineered biomimetic materials for intestinal mucosal healing (Transfer)

PROJECT SUMMARY/ABSTRACT
Despite continual improvement in the treatment of inflammatory bowel disease (IBD), achieving mucosal
healing remains difficult for many patients with IBD. A key hallmark of IBD is a compromised mucosal barrier
leading to erosions and ulcerations of the epithelium, which result in increased epithelial permeability and
uncontrolled immune response that induce and maintain intestinal inflammation. A healed and intact mucosa is
essential for preventing bacterial translocation from the lumen and modulating immune response to regain
intestinal homeostasis. However, limited success has been achieved for complete mucosal healing, likely due
to premature loss of drug efficacy and the off-target effect in normal tissue. Moreover, there remains a lack of
clear understanding on the complex healing process of the inflamed mucosa. Under chronic inflammation, how
the immune system and the microbiota may interfere with epithelial repair, thereby hindering healing, is largely
unknown. Therefore, there is a critical need for strategies that can target the inflamed mucosa to identify key
mediators in epithelial repair and promote healing. Without such strategies, mucosal healing will continue to be
a “therapeutic ceiling”. To address this challenge, we propose to engineer a biomaterial-based biomimetic
system that can selectively target the inflamed mucosa and locally release therapeutics to the
damaged epithelium. This system comprises a polymer-based hydrogel and drug-loaded nanoparticles
(NPs)—a hydrogel will create an interface at the inflamed mucosa, acting as a synthetic mucus layer, and the
NPs will release drugs locally to suppress bacteria, resolve inflammation, and repair the epithelium. Our
previous study showed that negatively charged hydrogels preferentially adhered to the inflamed mucosa based
on charge-mediated interaction in murine models of colitis and IBD patient biopsies. This proposed research
will combine the charge-based interaction with sol-to-gel transition using functionalized thermo-responsive
polymers to enhance the selective targeting. The NPs provide a platform for loading different drugs or drug
combinations to tackle the complex healing process at the site of inflammation. The overall objective of this
project is to maximize healing of the inflamed mucosa, enabled by drug delivery mimicking the natural mucosal
barrier and uncovering key mediators that regulate epithelial repair. The rationale is that determining
therapeutic efficacy of our biomimetic drug delivery system in preclinical models of IBD will provide a strong
scientific framework whereby new approaches to maximize mucosal healing can be developed. In this project,
we will pursue three specific aims: 1) a polymer-based synthetic mucus layer will be characterized and
optimized, 2) combinatorial NP drug delivery will be used to detect key mediators regulating epithelial repair,
and 3) therapeutic efficacy and mucosal healing by the drug-loaded biomimetic system will be determined.
These results will have a significant impact on repairing the mucosal barrier at the luminal-epithelial interface in
IBD, which may also open new horizons for treatment of many other mucosal barrier disorders.

Public health relevance
PROJECT NARRATIVE Despite advances in available treatment, achieving mucosal healing remains challenging for many patients suffering from inflammatory bowel disease (IBD). In this proposal, we will engineer a biomaterial-based biomimetic system that can selectively target the inflamed mucosa and locally release therapeutics to the damaged epithelium. The proposed research will use innovative approaches that employ drug delivery not only mimicking the mucus layer, but also as a tool to interrogate epithelial repair at the site of mucosal inflammation to shed light on mechanisms of mucosal healing for IBD and many other mucosal barrier disorders.